Designing a Mobile Obesity & Binge Eating Intervention for Implementation in Clinical Settings

Two in five U.S. adults have obesity, and up to 30% of treatment-seeking adults with obesity engage in binge
eating. With my K01 Research Scientist Development Award, I am designing and pilot testing FoodSteps, an
intervention that addresses both obesity and binge eating, delivered via mobile device to increase scalability.
My ultimate goal for this program of research is to establish FoodSteps as an evidence-based intervention that
can be broadly implemented in routine clinical practice. To achieve this goal, I need to design the intervention
(focus of my K01), understand how to implement it in practice (focus of this R03 proposal), and validate its
effectiveness and implementation in a hybrid trial (future R01 proposal). Thus, my overarching aim for this R03
small grant program is to apply service design methods to understand how to implement the intervention in
diverse clinics. Because embedding a new intervention into existing workflows is challenging, service design
focuses on improving the process of how patients and clinicians engage with each other and technologies
when delivering an intervention in practice. However, digital intervention research has largely ignored service
design, creating interventions that are not designed for the users and contexts in which they are implemented.
To ensure FoodSteps is maximized for clinical impact, I must attend to service design so the intended users
are positioned to and will use the intervention when it is delivered in practice. I will partner with three clinics
that are typical settings where people with obesity and binge eating present for treatment, and are the planned
sites of the future R01 trial: a primary care clinic, a lifestyle medicine weight management program, and an
outpatient eating disorders program. Using the 4-phase Double Diamond Model design process, I will apply
service design methods to create two design products that describe how FoodSteps will be embedded in each
setting: service blueprints (Aim 1) and implementation roadmaps (Aim 2). Service blueprints are diagrams of
the touchpoints when person-to-person and person-to-technology transactions occur throughout the
intervention delivery process. Implementation roadmaps will specify the implementation strategies and
adaptations to the intervention and settings that are needed to support FoodSteps delivery. Dedicated attention
to service design in advance of a R01 trial will (a) strengthen partnerships with the clinics to enhance readiness
for longer-term collaboration; (b) accelerate the timeline to deliver the intervention to patients due to already
completing implementation-preparation activities that are necessary before initiating data collection; and (c)
address potential challenges that could occur when conducting research in real-world settings so they are
avoided later. I am well suited to lead this study given my K01 progress learning and applying design methods,
including service design. Taken together, designing for the delivery of a mobile intervention for obesity and
binge eating will accelerate my science from a K01 to R01 trial, and propel digital intervention research toward
improved engagement and impact by aligning digital tools with their implementation contexts.

Public health relevance
PROJECT NARRATIVE Integrating new interventions into existing workflows is challenging, especially for digital (i.e., online, mobile) interventions; the current shift in the U.S. health care system to telehealth services makes understanding the integration of digital health tools necessary now more than ever. The proposed study aims to apply service design methods to design how to integrate a mobile intervention for obesity and binge eating into the workflows of three clinical settings, as these settings do not routinely deliver services for both obesity and binge eating. Aligning the mobile intervention with its implementation context will ensure the intended users are positioned to and will use the intervention when it is delivered in practice, maximizing its potential for clinical impact.